Nuclear actin filaments and phase separation: new drivers of heterochromatin repair

SUMMARY
DSBs occur in every cell because of exposure to environmental mutagens, such ionizing radiation,
chemotherapeutic drugs, UV light, toxic pollutants, and smoking, as well as in response to normal cell
metabolism, such as DNA replication. Repairing DSBs is particularly challenging in pericentromeric
heterochromatin, a poorly characterized region of the genome where the abundance of repeated sequences can
trigger aberrant recombination and widespread genomic instability. And yet, heterochromatin repair mechanisms
remain poorly understood. We discovered a specialized pathway that promotes faithful homologous
recombination (HR) repair in heterochromatin while preventing aberrant recombination. HR starts inside the
heterochromatin “domain” with resection, but it continues only after a striking relocalization of repair sites to the
nuclear periphery. Relocalization likely prevents aberrant recombination by isolating DSBs and their repair
templates away from ectopic sequences before strand invasion. We have recently discovered that the movement
occurs in two phases. Repair sites initially diffuse from the center to the periphery of the heterochromatin domain,
and this requires Nup98 and its phase separation properties. Next, nuclear actin filaments (F-actin) and myosins
drive the directed motion of repair sites to the nuclear periphery. How condensates contribute to these dynamics
is not clear. The mechanisms targeting condensate formation and F-actin assembly specifically to
heterochromatic DSBs are also unknown. Dysregulation of heterochromatin repair is likely one of the most
underestimated and powerful sources of tumorigenesis and identifying the mechanisms involved is essential for
understanding cancer etiology. Our central hypotheses are that immiscibility between Nup98 and HP1
condensates generate capillary forces that mobilize repair sites inside the heterochromatin domain, while DNA
damage response proteins work in concert with HP1 to target Nup98 and actin nucleators specifically to
heterochromatic DSBs. We will combine a wealth of imaging, genetic and biochemical approaches to investigate
the molecular mechanisms involved in this process. Expected positive outcomes of this research include the
systematic identification of the molecular machinery that protects heterochromatin from massive genome
rearrangements, enabling successful completion of HR repair. These studies are also expected to illuminate
missing links between nuclear architecture and dynamics, phase separation, repair progression, and the stability
of repeated DNA sequences. These results will have an important positive impact by identifying crucial safeguard
mechanisms used by normal cells to protect their genome from a variety of environmental threats. Dysregulation
of these pathways result in genome instability and tumorigenesis. Thus, we expect that the proposed studies
and future research will trigger exciting advancements in the prevention, early detection, and treatment of cancer
and other genome-instability disorders.

Public health relevance
PROJECT NARRATIVE Understanding the cellular responses to DNA double-strand break (DSB) is central to understanding the mechanisms responsible for genome instability and related diseases in response to environmental threats. Our studies aim to illuminate the mechanisms responding to DSBs in heterochromatin, a poorly characterized do- main occupying 30% of the genome. Even though defects in these pathways lead to aberrant recombination, a leading force of genome instability and tumorigenesis in response to environmental exposures, surprisingly little is known about DNA damage responses in this domain.